Role of the innate immune defenses in viral infections

The introduction of potent direct acting antivirals (DAA) has significantly improved the treatment response of patients with chronic HCV infection. However, at present, these interferon (IFN)-free treatment regimens are not available for most patients worldwide, partly due to the high costs. The WHO estimates IFN-based therapy will remain the sole available therapy particularly middle and low-income countries for the next several years. In addition, IFN remains important for HCV genotype 3 infected patients as part of a combination therapy with DAAs. The response rate to IFN-based therapy is negatively influenced by the pre-activation state of the innate immune response, which has a genetic component. At present, it is not known whether the responsiveness to IFN-based therapy can be improved. We have now completed and published a study that shows that rapid reduction in viremia within the first 24 hours of therapy with DAAs improves the IFN response of patients who had failed a standard course of pegylated IFN (PegIFN)/ribavirin (RBV) therapy in the past. We used NK cell phenotype and function as biomarker for IFN-responsiveness, because chronic exposure to low levels of HCV-induced endogenous IFN induces the ISGs STAT1 and TRAIL in NK cells, and enhances their cytotoxicity. We show that the 24h-virological response to therapy with PegIFN/RBV/DAAs correlated with an increase in pSTAT1 and STAT1 expression in NK cells, which was greater than during the previous unsuccessful course of PegIFN/RBV therapy. This was associated with an increase in NK cell function as measured by increased TRAIL secretion and expression of the degranulation marker CD107a that serves as a readout for cytotoxicity. In a follow up study, we asked whether the NK cell phenotype pre-treatment and at early treatment time points differs between HCV genotype 1b-infected patients who develop a sustained virological response (SVR) to DAA-based therapy (asunaprevir/daclatasvir or sofosbuvir/ledipasvir) and those who experience a virological breakthrough. Before treatment, patients who achieved an SVR had a higher percentage of pSTAT1 and TRAIL-expressing NK cells than those who developed a virological breakthrough. This was accompanied by a higher frequency of degranulating NK cells in response to target cells. Further, pre-treatment plasma CXCL10 levels were higher in patients with SVR, indicating a more prominent HCV-induced IFN- effect in this patient group. These results suggest the relevance of an endogenous IFN response in preventing breakthrough.